Molecular mechanisms of ribosome-mediated kinase signaling

Project Summary
Cells must adapt to shifting environmental conditions to ensure survival. And, while we know
that many of these insults target the ribosome and protein synthesis, we have recently begun to
appreciate the extent to which such cellular insults are directly sensed by ribosomes themselves
to initiate stress signaling pathways. Pioneering studies established that the status of translating
ribosomes is monitored to identify signs of global translational distress leading to activation of
the several signaling pathways including the ribotoxic stress response (RSR) and the integrated
stress response (ISR). Normally, the orchestration of translation initiation, elongation, and
termination rates enables maintenance of ribosome equilibrium on messenger RNAs (mRNAs).
However, cellular insults leading to the accumulation of damaged mRNAs inevitably result in
prolonged stalling of ribosomes within coding sequences and eventually to ribosomal collisions
which have been shown to be a key determinant for signaling translational distress. Low-level
collisions prompt a ribosome-mediated quality control, while abundant transcriptome-wide
collisions overwhelm the ribosomal rescue mechanisms and serve as a platform for initiating
general stress response pathways. Our previous studies showed that ribosome collisions recruit
and activate at least two cellular kinases, GCN2 and ZAK, triggering two distinct downstream
signaling cascades. In this proposal, we propose to define molecular mechanisms for how these
two kinases, GCN2 and ZAK, interact with ribosomes to activate downstream signaling. We will
use primarily biochemical approaches both in vivo and in vitro to identify binding partners of
these proteins and specific interactions critical to their output along the lifetime of their activity.
Our in vivo focused studies will primarily rely on mass spectrometry approaches at low and high
resolution. Our in vitro focused studies will evolve around a reconstitution approach using
purified proteins and diverse ribosome populations. The centrality of these pathways in
determining cell fate makes them critical to an understanding of cellular homeostasis in health
and disease.

Public health relevance
Project Narrative This project focuses on defining molecular mechanisms for ribosome-mediated activation of kinases GCN2 and ZAK to promote the ribotoxic stress response (RSR). Signaling pathways will be reconstituted from purified components and from in vitro extracts and subjected to molecular examination. These studies will reveal core mechanisms of the RSR with deep relevance to health and disease.